Mitochondrial Complex III Free Radicals in Dementia-Related Proteinopathy and Neuroinflammation

Despite a growing understanding of the various pathogenic mechanisms contributing to neurodegeneration,
there are currently no disease-modifying treatments available for Alzheimer’s disease (AD) or related dementias.
The main contributing factors in AD, including aging, tauopathy, and APP/amyloid-β pathology, are linked to
mitochondrial dysfunction. Mitochondria are the main energy producers in the brain, but they can also generate
excessive free radicals, or reactive oxygen species (ROS), which underlie diverse pathological cascades in AD
and other aging-related disorders. Accumulating evidence suggests that increased mitochondrial ROS acts as a
central, feed-forward driver of diverse pathogenic processes in dementia, including aberrant cell signaling,
protein misfolding, neuroinflammation, and neuronal dysfunction. However, the exact roles of mitochondrial ROS
in neural function and pathology are not clear due to low selectivity and suitability of currently available tools for
mechanistic and therapeutic studies. In particular, current tools for inhibiting ROS are not selective for individual
sites of mitochondrial ROS production and can disrupt redox homeostasis and cell metabolism. Testing of new
mitochondrial ROS inhibitors with superior selectivity could generate novel mechanistic insights and potential
disease-modifying treatment strategies for AD. We recently discovered novel compounds, termed Suppressors
of Electron Leak (SELs), which are unique in their precision: each acts on only a single target in the mitochondria
and only when that target is producing ROS. SELs inhibit mitochondrial ROS production without hindering energy
and metabolism in diverse model systems. Our preliminary results suggest that an SEL targeting ROS production
from mitochondrial respiratory complex III ameliorates AD-associated neuropathology and neuroinflammation in
vivo, and modulates astrocytic reactivity and astrocytic-neuronal interactions in primary cells. However, the exact
mechanisms of these effects are not known and the efficacy of SELs in different proteinopathies requires further
investigation. In the proposed studies, we will determine if and how SELs targeting complex III ROS modulate
glial responses and neuronal deficits in different models of tauopathy and APP/Aβ-associated pathology. Using
pharmacological and genetic manipulations of complex III together with diverse approaches, including
electrophysiology, transcriptomics, and redox imaging, we will test novel hypotheses that complex III ROS
promotes neuroinflammatory cascades and neuronal impairments caused by tau dysfunction and hAPP/Aβ
pathology (Aim 1), and that complex III ROS increases astrocytic reactivity and aberrant astrocytic-neuronal
interactions by enhancing immune-related signaling in astrocytes (Aim 2). Together, the proposed studies will
test if targeting complex III ROS can reduce multiple types of pathogenic processes associated with dementia
and inhibit aberrant astrocytic responses that promote disease. These studies could provide the first evidence
that site-selective blockade of mitochondrial ROS is an effective approach for reducing neurodegeneration, and
reveal novel molecular pathways underlying glial and neuronal impairments in disease.

Public health relevance
Mitochondria produce energy but they also release free radicals that can impair neural cells and contribute to disorders of the brain. Using experimental models, we will test the therapeutic efficacy of uniquely selective blockers of mitochondrial free radicals in dementia-linked pathology, and investigate new candidate mechanisms underlying the effects of free radicals on glial cells. These studies are expected to uncover novel roles of mitochondria in dementia-related processes and new treatment approaches for aging-related disorders of the brain.